Administrative Core

Abstract
This component of the application describes the role of the Administrative Core (AC) within the Institute
of Translational Genomic Medicine (ITGM) and the MSM Center for Genomic Diversity (CGD). Led by
Melissa B Davis, the AC supports genomics research projects through data analysis, training, and
coordination. It utilizes a three-tier organizational structure and collaborates with advisory committees
to guide its operations. The AC aims to enhance genomics research capabilities, infrastructure, and
faculty capacity at MSM. It focuses on expanding technology infrastructure, establishing analytical
pipelines, and ensuring standardized workflows. The AC follows a phased implementation strategy,
incorporating feedback to improve performance. It facilitates collaborations and oversees project
logistics, budgets, and compliance.